Teratology Society 2019 Annual Meeting - Trainee Travel Awards and Speaker Travel

The Teratology Society will hold its 59th Annual Meeting at the Sheraton San Diego Hotel & Marina, San
Diego, California—June 22–26, 2019. The scientific program covers a wide-range of cutting-edge research in
birth defects and disorders of developmental origin. The 2019 session topics include health disparities that
increase maternal morbidity and mortality and successful strategies to reduce complications of childbirth, a
review of choline supplementation to prevent or treat neurological disorders, advances in identifying
teratogenic agents, the treatment and management of birth defects across the lifespan, and the effects of
prenatal environmental exposures on the developing immune system. Other sessions will focus on the value of
zebrafish in identifying mechanisms of teratogenesis, ocean-borne risks to pregnant women and their babies
from aerosols and marine toxins to hurricane impacts, and the inclusion of pregnant women in clinical trials.
The keynote address will provide early insights in the Environmental influences on Child Health Outcomes
(ECHO) Program. Meeting attendees historically come from diverse professional backgrounds including basic
and clinical scientists from the academic, industrial, and government research sectors. The Teratology Society
Annual Meeting provides a unique forum where basic, clinical, and epidemiologic researchers come together to
share progress toward a common understanding of the causes and mechanisms of birth defects and
developmental disorders, and to translate these discoveries into clinical practice. New to the 2019 meeting is a
focus on innovation with a platform session devoted to finalists for the Society’s new Innovator Award.
The Society strives to encourage, engage, and mentor students and new/early stage investigators (trainees),
recognizing that its trainees represent the future of both the Society and the important scientific work
necessary to fulfill its mission to understand and prevent birth defects. This work extends to recruiting and
mentoring students from under-represented and under-served populations. The 2019 meeting recruitment will
include extensive outreach to San Diego’s large Hispanic population. Specific events at the Annual Meeting
encourage trainee participation, including a breakfast event where trainees are paired 1:1 with members for in
depth discussion of research and career paths; a career night to introduce trainees to members from different
disciplines; and a luncheon workshop highlighting professional development topics. Trainees are encouraged
to present their research; eight to ten trainees are invited to compete for the prestigious Wilson presentation
award in a special platform session, and all trainee poster presentations are judged for best poster
presentation awards. Trainees are also encouraged to serve as ad hoc members on Society committees,
thereby deepening their involvement within the Society. In this application, we are requesting funds to support
Travel Awards for trainees to attend the 2019-2023 Annual Meetings, and to partially support travel expenses
of key nonmember speakers who will help us educate and inspire these trainees.

Public health relevance
For fifty-eight years, the Teratology Society has promoted basic and clinical research to understand the causes and mechanisms of birth defects, the potential effects of drug, chemical, infectious or other exposures on the developing embryo/fetus, improve reproductive health, understand developmental origins of adult disease, and translate these discoveries into clinical practice. The Annual Meeting provides a forum for scientists, clinicians, and science policy regulators from academic, industrial, and government sectors to present cutting-edge research, exchange ideas and information, and engage in discussions among established experts in the field, new researchers, and students. The goals of the Teratology Society align with the goals of NICHD in advancing the knowledge on reproduction and embryo-fetal and postnatal development, as evidenced by the theme of the 2019 Annual Meeting, Sea Changes in Birth Defects Research and Prevention.